Training the Next Generation of Innovative and Collaborative Patient-Oriented Researchers to Reduce Obesity and Improve Cardiometabolic Health

PROJECT SUMMARY/ABSTRACT
My career focuses on research, clinical, and translational efforts to improve lifestyle treatment for obesity.
Obesity is a major contributor to cardiovascular
disease
(CVD),
accelerated by the current epidemic of highly
palatable energy dense food, reduced physical activity, and insufficient sleep. While weight loss can reduce
CVDrisk, sustaining weight loss is a major challenge for most individuals with obesity. It is imperative to identify
innovative and evidence-based strategies to promote greater and more durable weight loss. My collaborative
research program focuses on understanding predictors of successful weight loss maintenance and translating
those findings into strategies to improve lifestyle weight management programs. Specifically, I develop and
evaluate novel weight loss interventions, focusing on alterations of the timing or pattern of energy intake and
physical activity (PA). My studies involve rigorous, objective measures of free-living energy expenditure and
energy intake, and multi-disciplinary collaborations to comprehensively assess potential biologic, behavioral,
psychosocial, and environmental predictors of treatment response. Collectively, these studies provide a
framework and wealth of data for trainees to perform hypothesis-driven patient-oriented research (POR). I am
deeply committed to mentoring the next generation of innovative, collaborative clinical researchers to reduce
obesity and cardiometabolic disease risk. I have 8 years of mentoring experience supporting new and early-
stage clinical investigators in POR (undergraduate, graduate, and medical students; MD and PhD post-doctoral
research fellows; and junior faculty). My mentees have an excellent record of publication productivity, NIH grant
funding, successful career transitions, and retention in academic medicine. The K24 Mid-Career Investigator
Award will provide dedicated time for me to deliver focused mentorship to junior clinical investigators of
exceptional potential and capitalize on the outstanding mentoring, research, and training resources of our
campus. I will pursue leadership and administrative training, as well as develop multidisciplinary collaborations
to enhance my knowledge and skills in sleep/circadian physiology and qualitative methodology to extend the
breadth and reach of my obesity treatment POR program. I have assembled an experienced team of senior
clinical researchers with extensive mentorship experience and leadership roles in clinical and research training
programs on campus to serve as a K24 Advisory Committee to guide me during the K24 award period. My
specific aims are to 1) Mentor junior clinical investigators to create a pipeline of well-trained patient-oriented
researchers focused on obesity, nutrition, PA, and sleep, and 2) Build and enhance my collaborative research
program designed to rigorously evaluate strategies involving alterations of the timing or pattern of behaviors
(diet, PA, and sleep) to develop more effective lifestyle interventions to treat obesity, reduce cardiometabolic
disease, and improve health. As a dedicated physician-scientist, I am well-positioned to enhance the quality and
breadth of POR in weight management and CVD risk reduction and become a national leader in this field.

Public health relevance
PROJECT NARRATIVE Obesity is a major contributor to the risk for cardiovascular disease and the rates of obesity have continued to climb over the past 2 decades, driven by poor diet, inactivity, and reduced sleep. The support provided by this career development award will allow me to dedicate more time to training the next generation of clinical researchers to ensure they have the skills and expertise to address this important problem. It will also allow me to develop new research collaborations and research skills that will expand and enhance my own research program which is dedicated to improving lifestyle weight loss strategies to treat obesity, reduce chronic disease risk, and improve public health.